Post-ubiquitinational Regulation of I-kappa-B-alpha Proteolysis under Stimuli

DESCRIPTION (provided by applicant): IκBα is the major inhibitor of NF-κB, a family of transcription factors that control transcription of many inflammation-related genes. On the one hand, wounds and infections would never heal without proper inflammation; on the other hand, inflammation has long been associated with the development of cancer, especially metastasis. Therefore, the control of NF-κB transcriptional function is critical for human health. IκBα is a major inhibitor of NF-κB. Inflammatory stimuli, such as cytokines or infections, can trigger rapid degradation of IκBα via the ubiquitin-proteasome pathway. Consequently, NF-κB is activated to transcribe a spectrum of genes related to inflammatory responses. It has been shown that the SCFBTRCP ubiquitin ligase ubiquitinates IκBα upon stimulation. However, little is known about the post-ubiquitinational events of IκBα proteolysis. Polyubiquitinated IκBα still associates with NF-κB, indicating that ubiquitination of IκBα alone is not sufficient to release the inhibitory functin of IκBα. Therefore, the post-ubiquitinational regulation of IκBα is essential for IκBα turnover and NF-κB activation. Understanding this process could pioneer novel therapies to regulate inflammation. Recent studies in our lab suggest that a valosin-containing protein (VCP) and its cofactor, UFD1L, are involved in post-ubiquitinational regulation of IκBα. In this proposal, we wil dissect the mechanisms by which the VCP protein complex regulates IκBα post-ubiquitination. We will also strive to understand how the VCP complex delivers ubiquitinated IκBα to the 26S proteasome, and how the polyubiquitin receptors and deubiquitin enzyme (DUB) are involved in IκBα turnover and NF-κB activation.

Public health relevance
IκBα is the major inhibitor of NF-κB, a family of transcription factors that control transcription of many inflammation-related genes. Post-ubiquitinational regulation of IκBα is an important process that contributes to NF-κB and inflammation control.